Substance of Change: Evaluation of Web-Based Training for Mentors and Staff Serving Youth Impacted by Substance Misuse

“Substance of Change: Evaluation of Web-Based Training for Mentors and Staff Serving Youth
Impacted by Substance Misuse”
Approximately 1.6 million youth between the ages of 12-17 years old had a substance use disorder in the past
year. Another 8.3 million youth have lived with a parent who misused alcohol or drugs within the last year.
Substance misuse-affected youth (SMAY) are at heightened risk for conduct problems such as delinquency and
aggression, risky sexual behavior, truancy, and poor grades. Mentoring programs regularly serve SMAY due to
findings suggesting positive outcomes for these youth associated with being in a mentoring relationship.
Training of mentors and professional development of staff has been shown to be related to better quality and
longer-lasting mentoring relationships and more positive youth outcomes, in general; however, no evidence-
based, asynchronous, web-based, training programs have been located for mentoring programs serving SMAY.
The purpose of this project is to evaluate Substance of Change: Building Assets in Mentees Affected by
Substance Misuse (SOC), an interactive, multimedia, web–based, asynchronous training for mentors and staff
working with SMAY to determine its effects on mentor and staff outcomes. The content of the training course
builds upon content delivered in foundational, core pre-match mentor training and adds information and skills
related to the unique issues associated with mentoring SMAY. SOC includes content related to avoiding misuse
of drugs, coping with stress in a healthy way, and employing a strengths-based, asset-building approach to
mentoring vulnerable youth. Though the course addresses substance misuse generally, particular focus is paid
to avoiding opioid misuse. Given the enhanced skills needed by mentors and staff, the training will
acknowledge the ongoing needs and challenges that can emerge across the life cycle of the mentoring
relationship. As part of the current project, SOC will be expanded to add booster content to the course. After
boosters are created, four studies will be conducted. The first is a randomized controlled trial evaluation study
with mentors to examine the effectiveness of the training for improving mentors’ knowledge, attitudes, and
behaviors related to mentoring SMAY. The second study is a randomized controlled trial exploratory evaluation
study with mentoring program staff members to assess staff members’ knowledge, attitudes, and behaviors
related to providing support to matches that include SMAY. The third study is a qualitative interview study
with mentors to examine the applicability and usefulness of the training. The fourth study is a qualitative
interview study with mentoring program staff members to examine the factors influencing adoption of the
training for mentoring programs. Results from this work will inform a future large-scale randomized controlled
trial evaluation of SOC to determine its effectiveness on youth outcomes, including reducing mentees’
substance misuse and intention to use substance, and improving mentees’ healthy coping strategies.

Public health relevance
Project Narrative Children affected by substance misuse are a vulnerable and underserved population of youth. Supporting their healthy growth and development is of utmost importance. The proposed evaluation of a web-based training for mentoring program staff members and mentors working with substance misuse-affected youth (SMAY) fills an important gap in service needs for the field of mentoring. Mentor training has been shown to support the development of close, long-lasting mentoring relationships; however, few training resources specific to issues relevant to mentoring substance-misuse affected youth exist. The main purpose of this project is to evaluate Substance of Change: Building Assets in Mentees Affected by Substance Misuse (SOC), an interactive, multimedia, web–based, asynchronous training for mentors and staff working with SMAY to determine its effects on mentor and staff outcomes.